Harnessing TNFa Signaling To Improve Therapeutic Response In Pancreatic Cancer

PROJECT SUMMARY
Effective treatment is an unmet and urgent need for patients with pancreatic ductal adenocarcinoma
(PDAC). PDAC is characterized by mutations of the KRAS gene, which occurs in >95% of cases.
However, targeting KRAS and its downstream signaling pathways, particularly the RAF-MEK-ERK
mitogen-activated protein kinase (MAPK) pathway has been clinically unsuccessful due to rapid
emergence of escape mechanism including autophagy. In this study, we made novel observation that
MAPK inhibition (MAPKi) results in rapid and dramatic secretion of tumor necrosis factor alpha (TNF),
which we found mediates both cell survival and death. Selective targeting of the pro-survival MAPKAPK2
(MK2) downstream f TNF signaling augments MAPKi-induced autophagy and cell death. To rigorously
study these aspects, we have developed a 3-dimensional co-culture system to show that the anti-tumor
effect of combined ERK and MK2 inhibitors is powerful enough to overcome the protection provided by
adjacent cancer-associated fibroblasts (CAFs) and kill PDAC cells. We made observations that targeting
MK2 induces favorable immunological changes that could potentiate checkpoint immunotherapy.
The overarching goal of our proposal is to perform deeper and more comprehensive mechanistic studies
to support development of novel therapeutic combinations that can be delivered to PDAC patients as
clinical trials. To achieve this goal, we propose the following three Aims:
1. Aim 1: We will study the role of MK2 in autophagy in PDAC and CAFs using a new 3D spheroid
culture system. We will determine the mechanism by which MAPKi-induces autophagy.
Furthermore, we will identify new interacting partners of MK2 through a novel proteomic approach.
2. Aim 2: We will develop new genetic mouse models with conditional MK2-deletion to
systematically dissect the role of MK2 in different cell types in PDAC progression and shaping the
tumor microenvironment.
3. Aim 3: We will assess the combination of MK2 plus MAPKi and chemotherapy using a repertoire
of thirty patient-derived xenograft models. We will perform additional studies using state-of-the art
techniques and mouse models to develop novel immunotherapy regimens that will be rigorously
tested.

Public health relevance
PROJECT NARRATIVE We found that targeting the oncogenic KRAS-MAPK pathway in pancreatic cancer cells leads to marked induction of TNF secretion, which drives both death and survival including autophagy. Selective inhibition of MK2, which controls the survival signaling, aggravates TNF-mediated tumor cell death. On this basis, we will investigate the mechanisms by which MK2 signaling controls cell survival in cancer cells and shapes the surrounding fibroblasts and immune cells, with the overarching goal of developing novel therapeutic strategies that can be advanced into the clinic.